scDECO: A novel statistical framework to identify differential co-expression gene combinations systematically using single-cell RNA sequencing data

Project Summary
Recent single-cell RNA sequencing (scRNAseq) studies have revealed complex tumor
ecosystems characterized by intricate interactions between heterogeneous cell types and
diverse transcriptional programs. Differential co-expression (DC) analysis is emerging as
a crucial complement to the standard differential expression analysis (DE) for gene
profiling data. DC analysis can detect correlation changes between pairs of genes across
different modulating conditions. However, most DC analysis approaches are originally
designed for use on either microarray or bulk RNAseq data. There is an urgent need to
develop advanced DC analytical techniques that are tailored to the characteristics of
single-cell data, study design and biological objectives.
In Aim 1, we will develop a novel, flexible Bayesian model-based framework
named scDECO to improve the accuracy of identifying DC gene combinations using
scRNAseq data. Using data generated from various scRNAseq experiment protocols, we
will evaluate the proposed scDECO algorithm and perform benchmarking analyses to
compare our proposed approaches to current approaches. These analyses will provide a
better understanding of the advantages and limitations of these methods.
In Aim2, we will implement the scDECO algorithm using scRNAseq datasets from
melanoma and prostate circulating tumor cells. By identifying sets of clinically relevant
DC gene pairs using single-cell data, the findings can promote understanding of the
transcriptional co-regulatory processes in cancer stem-like cells and other cells in the
tumor microenvironment. Furthermore, the proposed framework has the potential to
improve clinical disease severity prediction by incorporating gene co-expression
information into risk score calculation. The predictive performance of the proposed
algorithm will be further evaluated using both scRNAseq and bulk RNAseq data. Finally,
in Aim3, freely available R/Bioconductor software packages will be distributed. The
R/Bioconductor environments are both very commonly used by biomedical researchers.
Ultimately, this proposed framework will accelerate studies seeking to understand the
differential co-regulatory transcriptional activities in tumors.

Public health relevance
Project Narrative We plan to develop a novel statistical analytical tool for detecting coordinated changes in genetic activities between various cell types from heterogeneous tumor samples using single-cell RNA sequencing (scRNAseq). We will develop a system of constructing risk score functions to predict patients’ clinical disease severity based on the results from our analyses. We will demonstrate the implementation of the proposed framework in caner contexts using datasets from melanoma and advanced prostate cancer patients.